Premenopausal bilateral oophorectomy and biomarkers of Alzheimer’s and cerebrovascular diseases

PROJECT SUMMARY / ABSTRACT
The social and economic implications of dementia is greatest in women because of their longer life expectancy
and resulting elevated risk for dementia compared to men, and this risk of dementia in women may be, in part,
modulated by ovarian hormones. Although premenopausal bilateral oophorectomy (PBO) is associated with a
reduced risk of ovarian and breast cancer, it is also associated with an increased risk of dementia and other
neurological diseases later in life. It is estimated that one in ten U.S. women have undergone abrupt endocrine
disruption by having their ovaries removed before reaching natural menopause and this rate is even higher in
African American/Black (AA) women. For the large number of women who underwent prophylactic PBO over
the past decade, it is critical that the pathologic mechanisms by which PBO influences the risk of dementia
should be determined in a rigorous manner for preventive approaches. The most common pathologies that
contribute to cognitive impairment and dementia are Alzheimer's disease (AD) and cerebrovascular disease.
Our goal is to understand the effects of abrupt disruption of ovarian hormones before the onset of menopause
on imaging biomarkers of AD and cerebrovascular disease pathophysiology later in life. We will enroll 150
women who underwent PBO and 150 women who did not undergo PBO drawn from a well-characterized and
established population-based cohort. Because our current cohort is predominantly White in Mayo Clinic
Rochester, we plan to enrich this cohort with a new AA cohort from Mayo Clinic Florida to reach a sample of
400 women (200 with and 200 without PBO). We hypothesize that imaging biomarkers of AD and
cerebrovascular disease, and cognitive function will be abnormal both cross-sectionally and longitudinally in
women who underwent PBO compared to referent women who did not undergo PBO, and that this difference
will be modified by race (AA versus White), age at PBO, and APOE ε4. Findings from the proposed project
have implications both for research and for clinical practice. Findings will contribute to clarifying the
mechanisms underlying the development of dementia in women who underwent PBO. In addition, they hold
the potential to alter the clinical practice paradigms related to PBO for non-malignant indications and outside of
the setting of high genetic risk of ovarian cancer. For the one in ten women currently facing the decision to
undergo PBO, determining the late life effects of PBO on the brain is critical for maintaining cognitive health in
the long-term.

Public health relevance
PROJECT NARRATIVE Women who undergo bilateral oophorectomy before the onset of menopause have an increased risk of aging- related neurological diseases including dementia. Our goal is to understand the effects of abrupt disruption of ovarian hormones before the onset of menopause on imaging biomarkers of Alzheimer's and cerebrovascular disease pathophysiology later in life. The findings will provide critical insights guiding the healthcare professionals and the women considering premenopausal bilateral oophorectomy for non-malignant indications and outside of the setting of high genetic risk of ovarian cancer.